DATA COORDINATING CENTER FOR THE FETAL BODY COMPOSITION AND VOLUMES STUDY

Support the Fetal Body Weight Compositions and Volumes Study, to design and implement a web based data mangment system capable of receiving and processing automatically uploaded ultrasound data ( imaging and biometric) from 2D and 3D measurements of images of singleton and twin gestations collected from pregnant women using 4D View GE Healthcare technology MAY SUPPORT Z1AHD008852